Behavioral and physiological assessment of adolescent and therapy dog interactions

Project Summary
Animal-assisted interventions (AAIs) are an increasingly popular approach for addressing a number of socio-
emotional challenges for youth. One area of particular clinical importance is the treatment of social anxiety in
adolescence, and initial evidence suggests that interacting with animals can reduce stress and anxiety.
However, little research has tested if this benefit extends to adolescents at risk for social anxiety. Furthermore,
there is a high level of variability in how AAIs are implemented, but little data on how specific interactions
between therapy dogs and participants can promote anxiety reduction.
The overall objective of this study is to assess how specific interactions between participants and dogs relate
to changes in adolescents’ self-reported anxiety and physiological reactivity. The specific aims of this project
are to assess 1) the temporal relationship between adolescent and therapy dog behaviors and adolescent
physiological reactivity, and 2) the effects of affiliative or stress-linked behaviors demonstrated by adolescents
and dogs on measures of anxiety in adolescent participants. These aims will be achieved by leveraging
existing video, self-report, and psychophysiology data collected during a laboratory-based study assessing the
effects of therapy dog contact on social anxiety in adolescents (5R03HD091892). Videos will be coded for
adolescent interactions directed towards therapy dogs as well as therapy dog behaviors. Behavior codes will
then be linked to existing self-reported adolescent anxiety and continuous psychophysiology data (skin
conductance level) to assess the effects of specific interactions on AAI efficacy.
This study represents a significant methodological innovation within the field of AAI research by combining
observational video data with objective physiological data to better understand the timing and effects of how
particular interactions within AAI can produce anxiety reducing responses with precise resolution. In addition,
this study explores the effects of the interaction between adolescent behavior and dog behavior on the efficacy
of the intervention. Therefore, this work represents a critical step in informing how AAIs can be optimally
designed to maximize effective interactions.

Public health relevance
Project Narrative The goal of this study to assess how specific interactions between adolescents and dogs during animal-assisted interventions relate to changes in participants’ self-reported anxiety and physiological reactivity. This study will provide data on how animal-assisted interventions can be optimally designed, and the unique effects that dogs may have in this setting.